Vascular Mechanisms of Hypertension-in-Pregnancy

Project Summary/Abstract Preeclampsia is a complication of pregnancy characterized by hypertension (HTN-Preg) and intrauterine growth restriction (IUGR), with unclear mechanism and limited remedies. We and others have shown that: reduction in uterine perfusion pressure (RUPP) and infusion of sFlt-1 or TNFα in pregnant (Preg) rats reduce vascular relaxation and increase vasoconstriction (VC) and BP; however, the vascular and uterine targets are unclear. Normal pregnancy involves extensive uteroplacental and vascular remodeling, and matrix metalloproteinases (MMPs) and related A Disintegrin And Metalloprotease (ADAM) family maintain adequate tissue remodeling. We have found decreases in uteroplacental and vascular MMP-2 and -9, and increases in MMP-1 and -7 in RUPP, and sFlt-1 and TNFα infused Preg rats. We have also discovered that MMPs not only degrade extracellular matrix (ECM) proteins, but also affect vascular function via effects on the Endothelium, Vascular smooth muscle (VSM) and ECM (EVE), such that MMP-2 and -9 are vasodilators (VD) while MMP-1 and -7 are vasoconstrictors (VC). Also, in search for the upstream mechanisms that trigger the changes in MMPs, our data suggest that ADAM-17, a sheddase and TNFα converting enzyme, is increased in RUPP rats, and infusion of ADAM-17 causes MMP imbalance, and increases circulating TNFα and sFlt-1, VC and BP in Preg rats. These new findings led us to the novel hypothesis that disruption of VD/VC MMP balance is a major mechanism of impaired EVE-dependent vascular pathways and HTN-Preg. Increased ADAM-17 activity triggers disruption of MMP balance. Consequently, correcting MMP imbalance by upregulating VD MMP-2 and -9 or downregulating VC MMP-1 and -7, or reducing the upstream ADAM-17 activity should improve EVE- dependent vascular pathways and HTN-Preg. Studies will be performed on Preg rats; RUPP, sFlt-1 and TNFα- infused rat models of HTN-Preg; Preg rats infused with ADAM-17, MMP-1 or -7, or treated with MMP-2 and -9 inhibitors, neutralizing antibody or siRNA; and MMP-2 and -9 deficient mice. Mechanistic studies at the whole animal, uteroplacental, microvascular and molecular levels will provide in-depth analysis of the mechanisms linking ADAM-17 and MMP imbalance to impaired EVE-dependent vascular pathways and HTN-Preg. The specific aims are to test the hypotheses that: 1) Disruption of VD/VC MMP balance during pregnancy is sufficient to impair EVE-dependent vascular pathways and cause HTN-Preg. 2) Increased ADAM-17 activity is an upstream mechanism that triggers disruption of VD/VC MMP balance, leading to impaired EVE-dependent vascular pathways and HTN-Preg. 3) Interventional correction of MMP imbalance and ADAM-17 activity is a central target to improve EVE-dependent vascular pathways and BP in HTN-Preg. These studies should provide a better understanding of the role of MMP imbalance and ADAM-17 in HTN-Preg, and highlight the potential usefulness of correcting MMP imbalance and ADAM-17 activity in the management of preeclampsia.

Public health relevance
Project Narrative Preeclampsia is a complication of pregnancy characterized by hypertension and fetal growth restriction; however, the underlying mechanisms are unclear. The objective is to test the hypothesis that an imbalance between vasodilator matrix metalloproteinases MMP-2 and -9 and vasoconstrictor MMP-1 and -7 triggered by an upstream increase in ADAM-17 activity is a major mechanism of inadequate uteroplacental remodeling and vascular dysfunction in hypertension in pregnancy. Disruption of the vasodilator/vasoconstrictor MMP balance results in inadequate uteroplacental remodeling, decreased vasodilation, increased vasoconstriction and hypertension in pregnancy, and consequently correcting MMP imbalance by upregulating vasodilator MMP-2 and -9 or downregulating vasoconstrictor MMP-1 and -7 or reducing the upstream ADAM-17 activity should improve uteroplacental remodeling, promote vasodilation, and reduce vasoconstriction and hypertension in pregnancy, and thereby provide a new approach for the management of preeclampsia.